Core A: Administration, Communication and Project Management

CORE A: SUMMARY/ABSTRACT
This Program Project comprises four individual projects, which will: extend the WISDOM Study to evaluate the
use of subtype-specific risk models and associated screening recommendations in improving key metrics of
screening outcomes (Project 1); continuously develop better subtype-specific risk models using large
population cohorts and cases where we have imaging and genomic information that can be validated using the
WISDOM Study and other cohorts (Projects 2 and 3); and use the MISCAN model to estimate the long-term
benefits, harms, and cost-effectiveness of the subtype-specific risk approach and set thresholds/milestone
goals for subsequent updates to the WISDOM platform (Project 4).
The primary aims of the Administration, Communication and Project Management Core are to ensure program
integration, collaboration and scientific advancement by providing project management leadership and
administrative support to the Projects and Cores in four areas: Communications and meeting coordination, Project
management and oversight, Partnerships and external relations, and Program integration support.
Aim 1: Administrative Support to facilitate communication amongst investigators, projects,
participants, public, private partners, NCI, DSMB, Scientific Advisory Board
Aim 2: Provide project management for all of the projects within this P01 - support and tracking of the
individual projects and cores to ensure that all projects are completed on time and on budget
Aim 3: Facilitate transition of successful products and models developed within the Program Project and
support WISDOM protocol development as part of the WISDOM Stakeholder process.
The Administration, Communication and Project Management Core is the organizational hub of the Program
Project. A strong organizational hub focused on program progress, information exchange and readily available data
and resources is of utmost importance for the success of the Program. This includes the Cores and Projects
targeting risk assessment, imaging, iterative testing of risk models and screening thresholds, data collection
and educational tools, as well as managing advisory boards and importantly, stakeholder development and
ongoing engagement. A critical role of Core A is to facilitate collaboration and communication across projects
and teams, a role which Core A’s leadership has demonstrated within Athena, WISDOM, I-SPY 2, and MCL
consortium with great success. This is an experienced, multidisciplinary team capable of leading and managing
large, complex clinical trials with integrated biomarker components that has a proven track record for rapidly
and successfully integrating new processes and procedures using tested, systems-based approaches for
management and project execution.

Public health relevance
CORE A: NARRATIVE The overall goal of the Program Project is to develop and study improvements in breast cancer risk assessment and use these to see how they can make breast cancer screening better. The Administration, Communication and Project Management Core will be responsible for overall project management and communications, partnership development with payors, stakeholder engagement, dissemination of educational materials, and will facilitate the successful transition of products and models developed within the projects to support WISDOM protocol development and implementation.